CONTROL AND ACTIVATION OF THE TUMOR NECROSIS FACTOR RECEPTORS

PROJECT SUMMARY
The goal of this proposal is to determine the rules governing the activation of the receptors in the tumor
necrosis factor receptors super family (TNFRSF), for aiding the development of therapeutic antibodies
targeting these receptors. There are genuine needs for in-depth understanding of the mechanism by which
these receptors are activated, as many of them are targets for antibody-based immunotherapy. While receptor
activation accompanying receptor clustering is a general phenomenon observed for receptors of the TNFRSF,
existing approaches of developing agonistic/antagonistic antibodies rely largely on trial and error, and no
correlation between antibody affinity and functionality has been observed. The proposed research is based on
our recent finding that, for a few members of the TNFRSF, the receptor transmembrane helix (TMH) alone can
mediate higher-order receptor clustering to drive downstream signaling and that an important role of the
receptor ectodomain in the absence of ligand is preventing the TMH-mediated receptor activation. Thus
developing antibodies that specifically modulate the auto-inhibitory state of the ectodomain would yield more
selective and efficient activators or inhibitors of the receptors. To investigate the general applicability of this
mechanism, we will perform structural and functional studies of receptor TMH oligomerization and pre-ligand
association for other members of the TNFRSF. Based on our understanding of the mechanism of receptor
autoinhibition, we will develop high-throughput technology for discovering antibodies that activate or inhibit
members of the TNFRSF in conformation-specific manner. Specifically, in Aim 1, we will perform a thorough
survey of receptor TMH clustering to identify TNFRSF members with TMHs that are capable of forming higher-
order interaction network and driving signaling. In Aim 2, we will characterize the pre-ligand association
structures for a few representative members of the TNFRSF to understand how receptor ectodomain physically
inhibit TMH clustering. In Aim 3, we will broadly survey the basic requirements of receptor activation to test our
proposed 3-2 rule of receptor activation. In Aim 4, we will exploit the autoinhibition concept to implement a
yeast display technology to screen for nanobodies/Fabs that specifically break or stabilize the pre-ligand
ectodomain association, as means of activating or inhibiting the receptors, respectively. The proposed
research will significantly advance our mechanistic understanding of receptor activation for the TNFRSF while
potentially discovering specific agonistic or antagonistic agents for several TNFRSF members such as DR5,
TNFR1, TNFR2, OX40, 4-1BB, CD40, and GITR, all of which are important immunotherapy targets.

Public health relevance
PROJECT NARRATIVE Members of the tumor necrosis factor receptor superfamily (TNFRSF) regulate proliferation of immune cells or induce programmed cell death, and many of them are candidates for antibody-based immunotherapy, e.g., antagonists of TNFR1/2 and CD40 for treating autoimmune and agonists of OX40 and 4-1BB in cancer immunotherapy. Recently, we made an unexpected finding that, for a few members of the TNFRSF, there is a defined auto-inhibitory state that keeps the receptor inactive in the absence of ligand. The proposed research aims to investigate the general applicability of this finding and its mechanistic basis, while developing new antibodies that specifically modulate the auto-inhibitory state for potential treatment of autoimmune diseases and/or cancer.